Endogenous stem cells in jaw joint cartilage and ligament regeneration

Project Summary
Resident tissue-specific stem cells serve to repair and maintain many adult organs; however mammalian joint
cartilage and ligaments have a very poor capacity for intrinsic repair. This lack of robust endogenous repair
may be at the root of many degenerative diseases of joints, in particular osteoarthritis. Dr. Smeeton's
postdoctoral work in Dr. Gage Crump's lab at USC uses the highly regenerative zebrafish to investigate the
role of stem cells in rebuilding the cartilage and ligaments of the jaw joint. As in mammals, surgical injury to the
ligament supporting the zebrafish jaw joint results in loss of articular cartilage. However, a remarkable
difference from mammals is that both the ligament and joint cartilage subsequently regenerate in zebrafish.
The aims outlined in this proposal will build on Dr. Smeeton's extensive preliminary data establishing this new
surgical model and make use of novel transgenic and CRISPR/Cas9 knock-in lines to investigate the timeline
and major cellular events of jaw joint regeneration (Aim 1), the respective roles of Sox9+ and Sox10+ stem
cells in rebuilding ligaments and cartilage (Aim 2), and the molecular events driving regeneration (Aim 3). Aim
1 will be completed in the K99 phase. Aims 2 and 3 will be initiated during the K99 phase under the mentorship
of Dr. Crump and her advisory committee and then completed during the R00 phase. In the long term, insights
gained from studying the role of endogenous Sox9/10 stem cells in the zebrafish jaw joint could be harnessed
to awaken analogous cell populations in mammalian joints to improve repair.
The project and mentorship plan outlined in this proposal were designed to lay the groundwork for Dr.
Smeeton's independent research program. Following her postdoctoral term, her goal is to obtain a tenure-track
Assistant Professor position at a top-tier academic research institute. Using her novel surgical models and
state-of-the-art genetics and imaging methods in zebrafish, her goal is use the zebrafish jaw joint to learn how
to better rebuild cartilage and ligaments from resident stem cells – a topic with a clear relevance for human
health. During the K99 phase, both her scientific and career development will benefit from the expertise in
zebrafish skeletal development and regeneration of her mentor, Dr. Crump. In addition, regular meetings with
her advisory committee will allow her to acquire new expertise in joint biology (Denis Evseenko), ligaments
(Amy Merrill), and RNAseq methodology (Andrew McMahon). Additional career development activities at USC,
such as grant-writing, presentation and mentorship workshops will prepare Dr. Smeeton for her transition to a
faculty position in the R00 phase. Dr. McMahon will be a particularly important advisor for the transition to
independence given his extensive experience directing faculty searches at Harvard and USC. With its
extensive network of craniofacial biologists and cartilage researchers, institutional support for career
development, and outstanding technical resources, USC is a vibrant and exciting place to establish Dr.
Smeeton's career in joint and craniofacial regeneration.

Public health relevance
A major reason why arthritis is the leading cause of disability in the United States is that the cartilage and ligaments of our joints do not heal well on their own. By understanding how a related vertebrate, the zebrafish, can naturally regenerate its joint cartilage and ligaments, novel types of treatments could be developed for arthritis patients.